ECM biomaterials for diabetic foot ulcers

A. SPECIFIC AIMS:
Diabetes is widespread in the United States, and its complications have devastating effects on health and quality of life. Impaired wound healing is a serious complication that leads to the development of chronic wounds in the lower extremities. Patients with such wounds display decreased mobility, and overall health, and are the most frequently subjected to limb amputation. Five year mortality following major amputation is over 80%. Wound care practices can be effective, but a large fraction of diabetic ulcers still persist or lead to amputation. Novel therapeutic strategies must focus on the pathological mechanisms underlying impaired healing in order to improve patient outcomes. Wounds become chronic due to diabetic hyperglycemia, including reduced blood flow, hypoxia, and aberrant behavior of immune cells, fibroblasts, and keratinocytes that are critical to healing. Recent unbiased analyses, such as single RNA seq, have revealed the critical involvement of fibroblasts and extracellular matrix (ECM) production. Surprisingly, little attention has been paid to the role of ECM proteins as negative modulators of healing. Work in our laboratory suggests the contribution of the matricellular protein thrombospondin-2 (TSP-2) to diabetic wounds. Normally, TSP-2 is expressed in wounds and contributes to ECM remodeling and vascular regression, in part, by increasing and decreasing the levels of matrix metalloproteinase (MMP)-2/9 and lysyl oxidase (LOX) and ECM crosslinking, respectively. Our recent work has shown that TSP-2 is elevated in the wounds of diabetic patients and mice suggesting a correlation between compromised wound healing and high TSP-2 expression. These findings allowed us to put forward the overarching premise that abnormal ECM production and assembly contribute to prevention of wound closure. We obtained partial confirmation for this hypothesis by generating diabetic mice lacking TSP2 (dbdb-DKO mice) and observed normalization of healing. In this application, we propose studies to explore and exploit ECM phenotypes in diabetes. Specifically, we plan to characterize ECM abnormalities and their contribution to cell dysfunction in vitro and in vivo. In addition, the newly generated dbdb-DKO mouse will be used to probe a novel ECM phenotype. We also aim to translate our findings into a bioengineering approach that will provide proof-of-principle for the utilization of novel ECMs as part of a combinatorial therapeutic strategy. These studies will include ECM obtained from a TSP2 KO pig that we have created for the provision of clinical grade materials. Accordingly, the specific aims of this application are:
Specific Aim 1. To test the hypothesis that fibroblast dysfunction and altered ECM production and assembly in diabetes contribute to delayed wound closure.
We will perform wound healing in these mice and monitor recovery of biomechanical integrity, a critical aspect of healing. We will also perform in vitro studies to investigate the indirect impact of diabetes on cell functions by studying the interactions of dermal fibroblasts with ECM derived from WT or dbdb mice. Specifically, we will evaluate migration, production of traction forces, and contraction. Inclusion of cell-derived ECM and cells from dbdb-DKO mice will allow us to probe the role of TSP2 in greater detail. In order to obtain a broader understanding of the signaling pathways involved in the diabetes-induced fibroblast dysfunction we will perform bulk RNA-sequencing and pathway analysis of all genotypes.
Specific Aim 2. To test the hypothesis that novel engineered native constructs can restore healing in diabetic animals.
We have previously shown that decellularized skin constructs and skin-derived hydrogels from TSP2 KO mice can increase cellular integration, vessel maturation, and healing in diabetic mice. In this aim, we will combine such constructs with drug delivery approaches to develop combinatorial strategies. These studies will be complemented by skin-derived ECM derived from our newly created TSP2 KO pigs. Specifically, we will prepare drug-loaded TSP2-null constructs embedded with alginate microspheres to combat infections, reduce chronic inflammation and restore healing. Full thickness excisional wounds will be made and the rate of healing will be quantified through daily measurements of wound area. Additionally, wounds will be subjected to histological and immunohistochemical stains in order to assess wound closure, epithelialization, inflammation, angiogenesis, and ECM remodeling.
Completion of this project should allow us to establish a major molecular mechanism in impaired wound healing, which could inform the development of engineering solutions to non-healing wounds. In exciting parallel studies, we have generated a TSP2 KO pig, which we anticipate will be used to produce ECM-based products for clinical use. We believe the proposed rigorous studies in this application will provide significant support for the advancement of regenerative ECM constructs towards the clinic.

Public health relevance
Project Narrative: Diabetes currently afflicts 170 million people worldwide and nearly 26 million Americans (more than 8 percent of the population) and its complications have broad and devastating effects on the health and quality of life of these patients. A particularly significant and dangerous complication of diabetes is non-healing ulcerated wounds in the lower leg, which are the leading cause of amputations in the USA. In this application, we propose to study associated cell dysfunctions and improve healing by creating novel native engineered constructs capable of enhancing cell integration and evaluating their ability to improve healing in a diabetic mouse model.